Dopamine neurotransmission in Gulf War Veteran's Illness

ABSTRACT Because of uncertain pathophysiology, it is a challenge to effectively treat patients with Gulf War Veterans’ Illness (GWVI). For formulation of an effective therapeutic strategy it is important to explore its pathophysiology and understand neurocognitive bases of the symptoms. Most investigators believe that the illness is caused by exposure to pesticides and other chemical agents. Interestingly, many of these agents (e.g. permethrin and sarin) deplete dopamine in laboratory animals. These findings are important because neuroimaging studies have found attenuated dopaminergic activity and reduced functioning neural mass in the basal ganglia of GWVI patients. Further, most of the common symptoms of GWVI are elicited by depleted dopamine. Thus, a vast majority of patients complain of clinical depression, memory loss, and unexplained pain. Depletion of dopamine is believed to cause depressive symptoms by disrupting dopamine dependent processing of the brain reward system. Similarly, a number of clinical and cognitive experiments have reported memory deficits and spontaneous unexplained pain after dopamine is depleted. Therefore, both of these symptoms along with clinical depression, are common clinical symptoms in Parkinson’s disease. Thus, converging evidence from etiological, neuroimaging, cognitive, and clinical data suggests that dopamine neurotransmission is depleted in GWVI. We hypothesize that dysregulated dopamine neurotransmission is an important deficit in GWVI. In this study, we propose to examine validity of this hypothesis using a newly developed neurotransmitter imaging technique, called the single scan dynamic molecular imaging technique or SDMIT. In the proposed experiments tonic (resting) and phasic (task- induced) release of dopamine will be detected, mapped and measured in GWVI and healthy control volunteers. For measurement of the tonic release, binding potentials of dopamine receptor ligands (11C- raclopride and 18F-fallypride) will be estimated in the striatal and extrastriatal areas of the brain. The phasic release will be measured in GWVI and healthy control veterans during performance of tasks that elicit reward (a proxy for clinical depression), memory, and nociceptive processing. Comparison of the data acquired in the two groups will indicate whether tonic or phasic release of dopamine is dysregulated in GWVI. In all of these experiments we propose to use the ligand 11C-raclopride to study dopamine release inside the striatum and a high affinity ligand 18F-fallypride to study dopamine outside the striatum. We have to use separate ligands for the striatal and extrastriatal studies because receptor kinetic properties of none of the dopamine ligands allow detection of binding and displacement in the whole brain. Further, we propose to correlate deficits in task performance with the amount of dopamine release, to understand whether dysregulated dopamine neurotransmission is responsible for the symptoms of GWVI. Thus, the proposed study will examine involvement of dopamine neurotransmission and characterize the nature of dysregulation in GWVI. It will establish whether the dysregulation is an important deficit in these patients. The results will allow development of objective diagnostic criteria based on the pattern of dysregulated dopamine neurotransmission. More significantly, findings of the proposed study will allow development of novel strategies for treatment of GWVI.

Public health relevance
The proposed study will examine an important hypothesis concerning pathophysiology of Gulf War Veterans’ Illness (GWVI). Because of diverse symptoms and uncertainty about the nature of causative agent, there is no effective treatment for this illness. A variety of evidence suggests that dopamine neurotransmission is dysregulated in GWVI and it may be an important deficit in GWVI patients. In this study, integrity of the dopamine system will be examined to understand the nature of dysregulation and identify the brain areas damaged in GWVI. The findings will allow development of novel therapeutic strategies based on empirical data. This study is important for the VA because more than 30% veterans of the Persian Gulf War suffer from GWVI and an unusually high percentage (17%) of these veterans receive service-related disability compensation.